Infralimbic Ensembles and Extinction of Drug Memories

Abstract Addiction is a learning and memory disorder, wherein conditioned responses to seek drug lead to chronic relapse. These conditioned responses can be triggered by exposure to reminder cues associated with the drug, and they can be inhibited through a process called extinction. The prefrontal cortex, especially the infralimbic (IL) subregion in rodents, is commonly recruited during extinction learning to exert inhibitory control over behavior. This is true for a number of behaviors, including conditioned cocaine seeking, food seeking, and fear. However, preliminary data suggest that this region is not recruited during extinction of heroin seeking, an observation consistent with numerous reports suggesting the role of IL cortex may be fundamentally different for heroin seeking. Alternatively, there may be distinct neuronal ensembles within IL that drive versus inhibit drug seeking. The anatomical connections of IL include three major efferent targets known to regulate drug seeking, namely the lateral hypothalamus, the nucleus accumbens shell, and the basolateral amygdala. We propose that IL neuronal ensembles projecting to distinct targets will drive versus inhibit heroin versus cocaine seeking, respectively. Aim 1 of this NIDA R21 proposal will determine whether functional neuronal ensembles exist within IL that are capable of driving versus inhibiting heroin and cocaine seeking. Fos-­activated neurons will be tagged with designer receptors (TRAP-­DREADDs) and subsequently reactivated using the designer drug, clozapine-­N-­oxide. This chemogenetic form of memory retrieval will be used to examine the role of the original drug-­cue memory versus extinction memory on relapse. Aim 2 of this proposal will examine the efferent targets of these ensembles using the retrograde tracer AAVrg-­GFP. These experiments will determine whether the inhibitory function of IL is truly absent for heroin seeking, or whether it has been overlooked due to the use of inadequate methods targeting all IL neurons indiscriminately. Furthermore, this work will provide new insight into the specific neuroanatomy of drug memory engrams and the extent to which they can be exploited to reduce relapse.

Public health relevance
Project Narrative Opiate addiction is currently a major public health threat in the United States, and rodent models indicate that infralimbic prefrontal cortex function may be fundamentally altered by heroin exposure. This brain region normally functions as an "off switch" for drug seeking by virtue of its role in extinction memory. We will examine the anatomy and functionality of neuronal ensembles in infralimbic cortex that encode drug extinction memories, and test whether these inhibitory memory traces can be artificially reactivated to reduce relapse.